Leveraging a community-academic partnership to pilot a family-centered communication intervention for Latinx young adult childhood cancer survivors

PROJECT SUMMARY
Adult survivors of childhood cancer face a lifetime of health risks due to past cancer treatments, with an estimated
80% experiencing at least one severe or life-threatening chronic health condition by age 45. To receive the
recommended lifelong survivorship care, young adult childhood cancer survivors (YA-CCS) need to develop
skills to manage their own care as they age. Triadic communication among YA-CCS, parents/caregivers, and
clinicians is essential for YA-CCS to learn about their cancer history and develop these skills; however,
communicating about survivorship topics is complex and even more challenging for families who prefer a
language other than English. Language barriers and other social determinants of health (income, education,
race/ethnicity) contribute to health disparities among childhood cancer survivors, yet very few interventions have
addressed these disparities. Bilingual community health workers help connect underserved communities with
services such as cancer screening but have not been widely employed in cancer survivorship settings. New
strategies are critically needed to reduce communication barriers and improve survivorship care among YA-CCS
at risk for health disparities. To address these gaps, the applicant Dr. Smith will leverage her partnership with a
community organization serving predominantly Hispanic/Latino (Latinx) families of children with cancer in a
region in California with low socioeconomic status and high rates of non-English language preference. The
proposed study will develop, pilot test, and refine a culturally and linguistically tailored family-centered
communication intervention for Latinx YA-CCS and parents/caregivers. Specifically, the study aims to 1)
Evaluate survivorship-related communication gaps and linguistic and cultural communication preferences among
Latinx YA-CCS and parents through English and Spanish focus groups; 2) Develop a community health worker-
led intervention to facilitate communication among YA-CCS, parents, and clinicians, applying principles of
community-based participatory research to involve cancer survivors, parents, and community members in an
iterative intervention design process; and 3) Pilot test the communication intervention to evaluate feasibility and
acceptability among 18 YA-CCS–parent dyads and refine the intervention based on feedback. Through leading
this study, Dr. Smith will develop advanced skills in community-engaged research, family-centered
communication, and intervention science. She will do so through structured training with support from a strong
mentorship team with expertise in community-based participatory research, communication, behavioral
interventions, and cancer survivorship. Dr. Smith’s mentorship and training plan, combined with Stanford’s robust
institutional support for community-engaged research, are anticipated to launch Dr. Smith’s independent career
leading patient-centered, community-engaged clinical research studies to reduce health disparities among
childhood cancer survivors. This research fills an important gap by involving a novel population that is vulnerable
to health disparities (Latinx YA-CCS) and addressing a novel intervention target (triadic communication).

Public health relevance
PROJECT NARRATIVE The long-term health risks of childhood cancer therapy have been known for decades, yet adherence to lifelong survivorship care is poor and inequitable, and this leads to health disparities. Communication among young adult childhood cancer survivors, parents/caregivers, and clinicians is essential for survivors to learn to manage their care, but it is complex and even more challenging for families who prefer a language other than English. This project will address these gaps by partnering with a community organization to develop, pilot test, and refine the first culturally and linguistically tailored family-centered communication intervention for Latinx young adult childhood cancer survivors and their parents/caregivers, working toward the goal of improving survivorship care in this population at risk for health disparities.